Hijacking the Blimp1-Neuritin Axis to Promote Cancer by Follicular Regulatory T-cells

Project Summary
Recent studies have highlighted the vital role of nerves infiltrating the tumor microenvironment (TME) in
tumorigenesis and caner progression. The current research in this field is largely focused on the impact of
dysfunctions of autonomic nervous system or psychological stress-induced hormone network on the malignant
progression of cancer. The potential regulation of peripheral nerve system by immune cells in the TME, which
subsequently influences tumorigenesis, has not been extensively studied. The overall goal of this proposal is to
define how a specific Treg subset, called follicular regulatory T (TFR) cells, modulates the TME to promote cancer
by producing and utilizing a neurotrophic factor, which is an unexplored area in the field of cancer research. We
have recently reported the pro-tumoral activity of TFR cells, which depends on the expression of the transcription
factor Blimp1 (encoded by Prdm1). Further analysis revealed that higher tumoral TFR signatures along with
PRDM1 expression indicated increased malignancy and risk of metastasis in many cancers. Moreover,
intratumoral TFR cells compared to conventional Treg cells and their peripheral counterparts expressed higher
levels of neuritin (encoded by Nrn1), a neurotrophic factor implicated in tumorigenesis, while its mechanistic
action remains largely unclear. Notably, TFR signature and PRDM1 positively correlated with NRN1 expression
in cancer patients. Intratumoral TFR cells in mice with disrupted TFR suppression due to Foxp3-specific deletion
of Blimp1 had substantially reduced expression of neuritin. Most importantly, tumors from these mice and mice
lacking TFR cells had markedly reduced neurofilament accumulation compared to wild-type tumors, and
intratumoral TFR cells were enriched with gene signatures implicated in axonogenesis. We propose to define the
mechanisms by which TFR cells exploit the Blimp1-neuritin axis to regulate the TME and tumor progression, and
to define the capacity of TFR-derived neuritin in promoting axonogenesis in the tumor. Findings obtained here will
revolutionize our understanding of the tumor innervation and immunosuppressive TME, aiding in developing new
immunotherapeutic approaches to treat cancer.

Public health relevance
Project Narrative This study aims to establish the essential role of a unique immune cell subset, TFR cells, in tumorigenesis, and reveal an unconventional mechanism by these cells adopt to promote cancer. Insights gained from this project will open a new avenue of investigation in the field of cancer research, and formulate new immunotherapeutic approaches to treat cancer.